Research Education Core

Abstract/Summary – Research and Education Core
The Research Education Core (REC) of the University of Michigan E-STaR Center (MEL-STaR) builds on the
high-quality infrastructure of didactic and experiential learning in the first-of-its-kind Department of Learning
Health Sciences (DLHS). The REC will capitalize on the successes of the ARHQ competency-based Health
Infrastructures and Learning Systems (HILS) MS and PhD program(s) that are embedded in DLHS. Initiated in
2016, HILS remains the 1st and only masters and doctoral program in learning health systems in the country.
The overarching goal of the REC is to provide a training and mentoring mechanism leading to enduring careers
for LHS scientists with a specific emphasis on novel approaches to promote equity and inclusion in the LHS
workforce. More specifically, we will support LHS scientists to work and collaborate with local, regional, and
national groups to build coalitions and leverage existing socio-technical infrastructures necessary for
transformations in health systems, community organizations, and broader policies. Cohorts of diverse
scholars from multiple disciplines will learn together and focus on the skills and content knowledge
needed to promulgate careers as learning health scientists. For MEL-STaR predoctoral scholars, the REC
will support matriculation through the 36-credit hour HILS PhD program, incorporating didactic and experiential
leaning, rapid cycle, student-centered mentoring and feedback, and a commitment to diversity, equity,
inclusion, and social justice. For MEL-STaR postdoctoral scholars, the REC will utilize the well-tested and
effective infrastructure of the DLHS Medical Education Scholars Program (MESP), an internationally acclaimed
annual program that trained over 300 faculty and fellows at the University of Michigan. The REC will provide
the infrastructure for early career faculty and fellows to develop as leaders in LHS by providing didactic and
experiential learning opportunities through HILS and the embedded MEL-STaR labs. The overarching goal of
the REC will be accomplished through promoting four main components of effective patient-centered, cross-
sectoral research and infrastructure: 1) mentorship for rapid cycle research in learning health systems; 2)
engagement with systems, community, and stakeholder partners; 3) mechanisms to leverage grant funding
from federal and non-federal agencies; and 4) use of existing information systems and emerging data to
support PCOR/CER.